Chemical Exchange Saturation Transfer (CEST) MRI for the Characterization Small Renal Masses

Project Summary
An Academic-Industrial partnership between scientists and clinicians at the University of Texas Southwestern
(UTSW) Medical Center and Philips Research Hamburg and Philips North America (Philips) has been formed
with the purpose of translating the novel molecular MR imaging method, Chemical Exchange Saturation
Transfer (CEST), into a clinical tool for the assessment of Small Renal Masses (SRMs). CEST has already
demonstrated feasibility in neurooncology applications. The management of SRMs is challenging because a
substantial number of them are benign or indolent malignant tumors, leading to patient exposure to
unnecessary morbidity from biopsies and surgery. Non-invasive distinction between benign/indolent tumors
and aggressive tumors would allow for better risk stratification and patient management. While novel, CEST
has already been adopted by certain clinical centers for assessment in neuro oncology. Recently, our group
demonstrated the promise of CEST to the characterization of breast lesions. Here, we propose to broaden the
application of CEST to renal oncology by addressing the inherent challenges of application of CEST in the
abdomen and by optimizing CEST in patients with SRMs.
Our hypothesis is that technical development of CEST-MRI allows observation of aggressive tumor
microenvironment in SRM. Our goal is to advance CEST methodology to become a part of comprehensive SRM
evaluation protocol. The goals of the project will be achieved via the following Specific Aims:
Aim 1: To develop and optimize CEST methodology for SRMs on 3T human MRI system.
This is technical development Aim, where we will evaluate several approaches addressing major issues
associated with translation of CEST to kidney oncology applications: (i) improved resolution and fat separation,
(ii) acceleration of acquisition using pseudo-cartesian and undersampled algorithms,(iii) motion correction and
(iv) advanced Z-spectrum analysis methods.
Aim 2: To evaluate the optimized CEST-MRI as a predictive biomarker of SRM hystology.
The Aim's focus in on the translation of the CEST technology to SRM patients: (i) evaluation of the optimized
in a group of SRM patients: (ii) correlation of the CEST-MRI measurements with histopathology results and
correlation of CEST-MRI with glycogen deposition.

Public health relevance
Project Narrative This is an Academic-Industrial partnership project between scientists at the University of Texas Southwestern Medical Center and Philips Research Hamburg and Philips North America. The partnership has been formed with the goal of translating a novel molecular Magnetic Resonance Imaging (MRI) method, Chemical Exchange Saturation Transfer (CEST), into a reliable imaging technology for the characterization of Small Renal Masses (SRMs). Achieving this goal will allow improved diagnosis, prognosis and treatment, will cut unnecessary biopsies and complications, thus improving patient outcomes and decreasing treatment financial and psychological burden.